Toxic effects of trichloroethylene and its metabolite on placental cells at the maternal-fetal interface

PROJECT SUMMARY/ABSTRACT
Adverse birth outcomes are prevalent conditions that increase the risk of morbidity and mortality during
infancy and the development of chronic metabolic diseases in adulthood. Despite being multifactorial in nature,
the causes of adverse birth outcomes, particularly concerning placental dysfunction, are not well understood.
Maternal exposure to environmental contaminants is believed to contribute to these outcomes. As a
reproductive toxicologist, Dr. Elkin's research seeks to understand the role that maternal exposure to
environmental contaminants play in contributing to adverse birth outcomes involving placental dysfunction, and
to identify mechanisms by which these aberrant effects can be mitigated or prevented. This Transition to
Independent Environmental Health Research (TIEHR) Care Award will provide Dr. Elkin the opportunity to
increase training and experience to meet: 1) research development goals, including utilization of single-nucleus
technologies and establishment of an in vitro model to represent the syncytial barrier at the maternal-fetal
interface, and 2) professional development goals, including science communication, mentoring, and
management skills. In humans, maternal exposure to the industrial solvent trichloroethylene is associated with
increased risk of low birth weight and restricted fetal growth, conditions linked to placental dysfunction. For the
research component of this project, Dr. Elkin will investigate the biological mechanisms of the trichloroethylene
metabolite S-(1,2-dichlorovinyl)-L-cysteine (DCVC) contributing to restricted fetal growth by identifying
molecular factors underpinning disruption of placental function at the maternal-fetal interface. At the maternal-
fetal interface, several different cell types of trophoblast lineage have critical functions. Previously, Dr. Elkin
extensively characterized the effects of DCVC on HTR-8/SVneo cells, which model invasive extravillous
trophoblasts. Nevertheless, toxic effects on other important cell types at the maternal-fetal interface have not
been explored. Recently, Dr. Elkin's colleagues published promising preliminary data showing that DCVC
caused aberrant apoptosis, oxidative stress and inflammation in differentiated BeWo cells, a cell line that
models the interhaemal barrier of multinucleated syncytiotrophoblasts separating maternal and fetal
circulations. Using an in vitro approach, Dr. Elkin's project will expand on compelling preliminary data by: (1)
identifying other placental cell types vulnerable to DCVC at the maternal fetal interface using single-nucleus
RNA-sequencing (2) examining DCVC effects on mitochondrial energetics of differentiated
syncytiotrophoblasts and (3) determining if DCVC affects placental villous barrier function. The proposed
research will address the NIEHS goal of “advancing scientific understanding of the role that early exposure to
environmental contaminants play in impacting disease risk later in life.” The findings will inform various
stakeholders including lawmakers tasked with protecting the public and clinicians developing therapeutic
interventions to combat elevated risk of untoward complications, ultimately improving maternal/fetal outcomes.

Public health relevance
PROJECT NARRATIVE Maternal exposure to the environmental contaminant trichloroethylene (TCE) is associated with elevated risk of small-for-gestational-age (SGA), an adverse birth outcome that increases the risk for morbidity and mortality in infancy and chronic metabolic diseases in adulthood. This Transition to Independent Environmental Health Research (TIEHR) Career Award will provide training and research support to investigate the biological plausibility of TCE contributing to elevated risk of SGA by identifying molecular mechanisms underpinning disruption of placental cellular function at the maternal-fetal interface. The results of this research will offer valuable insights for policymakers and clinicians, helping enhance protective measures and therapeutic strategies to improve maternal and fetal health outcomes.